Administrative Core

The overall goal of the administrative core is to provide scientific and technical guidance for the development
and operation of the beamlines, provide administrative services for ongoing operation of the NE-CAT, and
oversee an active user program for both on-site and remote access. The administrative core also oversees the
development of RAPD, NE-CAT's automated data collection and analysis software, supports the NE-CAT Web
site, and interfaces with APS, ANL, and DOE. NE-CAT's administrative structure has evolved over the past 15
years into a highly cohesive and effective group. The NE-CAT Director, Dr. Steven Ealick (35% effort), has 25
years of experience in overseeing the development and operation of synchrotron beamlines. Dr. Ealick resides
in Ithaca, NY and travels to the Advanced Photon Source about once a month. Dr. Malcolm Capel is the NE-
CAT Deputy Director (20% administration) and is responsible for the day to day operation of the NE-CAT
Resource. The remainder of his effort is devoted mostly to beamline maintenance and improvements. Dr.
Kanagalaghatta Rajashankar is NE-CAT Associate Director (20% administration). He oversees the user
program and the remainder of his effort is devoted to user support, user training and outreach. Dr. Frank
Murphy is NE-CAT Assistant Director (20% administration). He oversees maintenance and development of
RAPD, and the remainder of his effort is devoted to user support, user training and outreach. The four person
management team is assisted at the APS by Ms. Cyndi Salbego, who administers the user program and NE-
CAT Web site, and a halftime administrative assistant in Ithaca (currently Ms. Judy Wood) who is responsible
for interfacing with the Department of Chemistry and Chemical Biology, College of Arts and Science, and
Cornell University infrastructure and for organizing, data gathering, and reporting. The remainder of the NE-
CAT staff comprises six staff scientists at APS, a halftime staff scientist in Ithaca, and two technicians. NE-CAT
receives regular input from the NE-CAT Resource External Advisory Committee and the NE-CAT Executive
Committee. The Administrative Core is responsible for allocating beamtime, which is coordinated with the APS
Users Office, for scheduling users, and for ensuring that APS safety protocols are followed. Finally, the
Administrative Core is responsible for collecting and reporting metrics that demonstrate impact of the resource.
These include monitoring beam time usage, number of users, number of groups, user funding sources, and
level of demand for NE-CAT beamlines. Productivity is measured by publications and PDB entries resulting
from NE-CAT data, and communicating scientific highlights. Finally, the Administrative Core is responsible for
monitoring training and dissemination activities, and for evaluating and promoting workforce and user diversity.